Hatching Organoids for Continuous Tissue Production Pipelines

PROJECT SUMMARY
Our evolving ability to bioprint cells to generate complex tissues and organs promises to revolutionize medicine
by overcoming donor organ shortages and immune rejection. However, a major limiting factor faced by the
bioprinting field is the complexity and cost in generating the billions to trillions of differentiated cells from induced
pluripotent stem cells (iPSCs) to yield the necessary quantities of patient-specific cells for organ-scale
bioprinting. We posit that organoids, owing to their mature cellular makeup, microarchitecture, and function,
could serve as ideal building blocks for bioprinting organ-scale tissues. However, typical organoid protocols
generate only 10-1,000 organoids, and their therapeutic potential is limited by batch-to-batch variability. While
we have previously demonstrated that organoids can be rendered into printable and densely cellular bio-inks,
organ scale bioprinting would require the synthesis of over ~1 million organoids. An optimal process for
generating millions of organoids for bio-inks would A) be driven by cell-intrinsic mechanisms not requiring
expensive exogenous growth and differentiation factors, B) would allow the temporal and spatial co-
differentiation of stem cells to the different fates that normally cooperate in vivo resulting in organoids more likely
to have the requisite functions to serve as optimal bio-inks and C) would be a continuous (i.e. batch-free)
differentiation process with no down-time or batch-to-batch variability, wherein new cells are continuously added
and mature organoids would be continuously extracted. To address the issue of media cost and co-
differentiation, our preliminary work has yielded transcription factor overexpression for driving coordinate
differentiation to divergent cell types in a growth factor-free fashion to yield mixed cell type organoids for
bioprinting. To apply this process at the million-organoid scale, we propose here to develop an ‘organoid farm’,
the first continuous organoid derivation process to generate millions of organoids in a continuous culture
bioreactor system. Differentially fate-specific programmed iPSCs will be inserted into alginate capsules,
continuously introduced into the culture, and developed to mature organoids. The input iPSCs will be
programmed to spontaneously ‘hatch’ upon maturation via maturation stage-dependent expression of alginate
lyase, a benign alginate-degrading enzyme, thus liberating the mature organoid in a form that is easily harvested
from the ongoing culture. While the proof-of-concept experiments proposed herein utilizes mixtures of iPSCs
programmed towards the endothelial and fibroblast fates that comprise the vascular tissue, this approach should
be applicable to the generation of any organoid type for bioprinting virtually any tissue or organ. Further
downstream applications of our organoid farm and hatching organoid techniques include automated organoid
purification and pooled genetic or pharmacological screening.

Public health relevance
PROJECT NARRATIVE Despite recent successes in forming intricate biological tissues, bioprinting is now critically limited by the lack of patient-specific cell and organoid sources; trillions of differentiated cells are necessary for high-throughput organ engineering experimentation. We propose to build the first continuous, batch-free, organoid production system, wherein stem cells are continuously added to a stir flask, and mature organoids are continuously extracted. Our method functions by encapsulating immature cells into alginate capsules, from which they ‘hatch’ upon maturation into differentiated organoids, enabling facile, large-scale extraction and purification of organoids for organ biofabrication applications.